THE PURPOSE OF THIS TASK ORDER IS TO SUPPORT THE NATIONAL INSTITUTE OF MENTAL HEALTH (NIMH) DATA ARCHIVE (NDA) IN ACCORDANCE WITH THE INCORPORATED ATTACHMENT 1: STATEMENT OF WORK.

THE PURPOSE OF THIS TASK ORDER IS TO SUPPORT THE NATIONAL INSTITUTE OF MENTAL HEALTH (NIMH) DATA ARCHIVE (NDA) IN ACCORDANCE WITH THE INCORPORATED ATTACHMENT 1: STATEMENT OF WORK.